Administration

The Administrative Core will be responsible for providing scientific administration and coordination, fiscal oversight and administrative support. To ensure optimal cooperation and communication, the Core will coordinate meetings at least every three weeks among the Program Project members, who are located at Children's Hospital Boston, the Dana Farber Cancer Institute, the CBER/FDA and Consejo Superior de Investigaciones Cientificas, CSIC, Madrid, using Web based media. The Administrative Core takes on added importance because of the geographic distance between the Program Project investigators, and will provide effective communication services. Due to special circumstances, the Administrative Core will also administrate and oversee funds allocated for postdoctoral fellows and supplies to one ofthe collaborators, Dr. Gerardo Kaplan at the CBER/FDA. This administrative activity includes purchasing supplies for the CBER/FDA site, as well as coordinating the hiring of personnel working at the CBER/FDA site, through the Children's Hospital Boston. Children's Hospital Boston and Dale T. Umetsu are responsible for the application and for collaborative research activities described.

Public health relevance
The Program Project will focus on inflammatory diseases including asthma and allergy as well as, and study the mechanisms of immune regulation. We will determine how a newly discovered family of genes called TIMs, regulate immune responses that cause these clinical problems. These genes have remarkably novel functions that affect immunity, and could lead to new therapies for asthma, allergy and autoimmunity